Improved ventilation of the edematous lung

Project Summary
Acute respiratory distress syndrome (ARDS) is treated by mechanical ventilation. Mechanical
ventilation is a lifesaving therapy but also causes additional ventilation induced lung injury (VILI). It is
not known whether VILI is attributable to overexpansion or cyclic collapse and reopening of lung tissue.
In this bioengineering project, we aim to elucidate the micromechanics of the ventilation injury
mechanism. We propose to test ventilation settings that keep the lung tissue expanded, allow collapse
and reopening or permit collapse without reopening, and then apply a new electrical determination of
alveolar-capillary barrier permeability. The new method is highly localized and independent of regional
edema degree. Combining information from ventilation history and permeability characterization, we
will determine cause and location of injury.

Public health relevance
Public Health Relevance Statement Acute respiratory distress syndrome patients are treated by mechanical ventilation, which assists oxygenation but at the same time exacerbates already-existing injury of the lungs. This proposal aims to elucidate how mechanical ventilation causes additional injury to the lungs and test a therapy for reducing the injury.